Penn Dermatology Research Training Program

Entering its 40th year, the overarching goal of the Penn Dermatology Research T32 Training Program is to
recruit diverse young investigators into biomedical research careers pertaining to the skin and its diseases, and
to provide them the training, mentorship, and skills to be successful in that career. Training and supporting the
developing careers of the next generation of investigators in dermatology research is critical to research
progess and innovation in cutaneous biology, skin diseases, and dermatoepidemiology, leading to novel
treatments for skin disease and improvements in overall human health. To most effectively support trainees in
dermatology research, we have developed approaches to: 1) recruit diverse trainees at early stages in their
careers by exposure to the excitement and impact of dermatology research; 2) support the research and
training of young scientists with established interests in the skin and its diseases; and 3) provide a rigorous and
supportive training environment that fosters development of skin investigators across disciplines. To these
ends we request support for: 2 long-term predoctoral fellowships to support the thesis research of MD PhD
students, PhD students, or MD students pursuing a Masters in Clinical Epidemiology (MSCE) degree; and 4
postdoctoral fellowships for MD, PhD, and MD PhD scientists. A particular emphasis of our training program is
to recruit and train physician scientists through a four-year dermatology research residency track. Our program
involves 36 highly qualified trainers with expertise ranging from clinical epidemiology, genomics, medical
informatics, microbiology, immunology, to developmental biology, stem cells, skin appendages, and
regeneration. Training activities are tailored to the stages of training and the type of research conducted by the
trainee. Trainees attend and present their research at a weekly Dermatology Research Seminar, a bi-weekly
Trainee Power Hour, and an annual Scientific Symposium & Trainee Retreat. Trainees receive formal
instruction in the responsible conduct of research, methods to enhance scientific rigor and reproducibility,
biostatical and analytical approaches, data sharing, and other appropriate data science training tailored to the
trainee’s individual needs. Skills workshops are conducted to develop grant writing and manuscript drafting
skills. These activites complement a rich set of professional and career development activites facilitated by
Penn’s post-doctoral and graduate programs. The training program is evaluated by conducting annual trainee
surveys, by an external advisory committee that meets yearly, assessment of research output (publications,
grants, awards), and tracking long-term career outcomes including leadership positions in academia and
industry. These approaches have been highly successful, resulting in diverse, rigorously-trained independent
investigators that go on to become academic leaders and independent scientists across the disciplines of
dermatology research. Continued support of this Training Program will fuel new mechanistic understanding
and therapeutic targets for skin disease, and improved health and quality of life for dermatology patients.

Public health relevance
The goal of the Penn Dermatology Research T32 Training Program is to train the next generation of independent investigators to become leaders in cutaneous biology and dermatology. Skin diseases are very prevalent, represent a major health burden, and have a profound impact on quality of life. By training diverse, multi-disciplinary investigators that span basic, translational, and clinical research, we seek to improve mechanistic understanding and identify novel therapeutic targets for skin disease, leading to improved health and overall quality of life.